Contract support services for Tobacco Control Research Branch

This contract provides contract support services for the expansion of resources, awareness &utilization of NCI's Smoking Cessation Website &Quitline managed by the NCI Tobacco Control Research Branch located within the NCI Division of Cancer Control and Population Services.